Prevention and Methodology Training

PROJECT SUMMARY/ABSTRACT
Since 2005 the Prevention and Methodology Training Program (PAMT) T32 has met a critical need in the
training of drug abuse prevention scientists by nurturing scientists focused on integrating prevention science
and highly innovative methodology. The objective of PAMT, which is unique to NIDA’s portfolio, is to produce
scientists who lead the application of cutting-edge methods to emerging critical research needs in the
prevention of substance use and addiction. We do this in the context of Penn State’s long-standing dual
commitment to innovation in data collection, design, and statistical analysis methods and to impactful research
on the etiology and prevention of substance use and addiction across the life span. Building on PAMT’s long-
term success training 83 prevention scientists to date, we propose to enhance this successful pre- and post-
doctoral training program with (1) increased depth in formal training opportunities related to our core
competency domains: substance use, prevention science, and innovative methods; (2) strategic initiatives to
build diversity in mentors, trainees, and training; and (3) expanded disciplinary integration by leveraging Penn
State’s deep investment in its new Consortium to Combat Substance Abuse. PAMT is administered through
the Edna Bennett Pierce Prevention Research Center. Drs. Jennifer Maggs and Stephanie Lanza, Program
Directors, and Dr. Rina Eiden, Associate Training Director, lead the program as distinguished substance use
researchers with expertise in prevention science and innovative methods. To achieve trainees’ individualized
training goals, the program offers (1) interdisciplinary instruction on substance use, prevention science, and
innovative methods; (2) mentored experiential training in all aspects of research; (3) training in professional
skills and the responsible conduct of research; (4) proseminars including workshops on methods, health equity,
cultural competence, and goal tracking; (5) a biennial visit to NIH; and (6) formal training in NIH grant-writing,
leading to many successful F31, R03, and K99 grant submissions. An Expert Advisory Committee will meet
annually to provide feedback and guidance related to training and diversity goals. Faculty mentors are leaders
in substance use, prevention science, and innovative methods, with strong track records of NIH support and
mentorship of early career scholars. Forty-five faculty mentors span disciplines such as human development
and family studies, biobehavioral health, sociology/criminology, psychology, and engineering. Our trainees
work toward novel solutions to mounting challenges related to substance use. The proposed renewal supports
7 pre- and 3 post-doctoral trainees per year, with strong institutional support for an additional 3 pre- and 1 post-
doctoral trainees per year. Together, this represents 25 pre- and 10 post-doctoral trainees in the 2021-2026
renewal period. PAMT trainees are engaged in cutting-edge work that rigorously integrates new methods into
prevention research, providing a seamless, holistic approach to understanding and preventing drug abuse. The
scientists we train will be at the forefront of this critical area for many years to come.

Public health relevance
PROJECT NARRATIVE Substance use and addiction persist as systemic public health problems; preventing them will improve the nation’s health, yet successful prevention is complex. The proposed interdisciplinary training program will produce a new generation of behavioral scientists who are experts in conducting rigorous, responsible, innovative research on the prevention of substance use and addiction. By integrating prevention science and innovative methods, these prevention scientists will be leaders in preventing harmful substance use and reducing social, disease, and economic burdens.